55th Annual Meeting of the Society for Leukocyte Biology

PROJECT SUMMARY/ABSTRACT
This proposal is to request support for the 55th Annual Meeting of the Society For Leukocyte Biology entitled:
“Leukocytes on the Wave for Translating Medicine”. The meeting will be held October 26-29, 2022 with an in-
person format. Funds derived from this proposal will be distributed in the form of travel awards that will provide
much needed assistance to young investigators and trainees. The Organizers of the 55th meeting are Domenico
Mavilio, MD-PhD, Department of Medical Biotechnology and Translational Medicine, Milan University, Milan,
Italy and Chen Dong, Ph.D., Institute for Immunology, Tsinghua University, Beijing, China.
SLB is the leading scientific society with a focus on leukocytes and their roles in the pathophysiology of acute
and chronic diseases. No other scientific meeting regarding study of the immune system focuses on the
leukocyte with the breadth and depth of SLB so the annual meetings sponsored by SLB fill this void. Therefore,
SLB is the premier society in the field of leukocyte biology, and convenes annually to promote scientific exchange
among researchers and support the career development of trainees and junior investigators. Funds derived from
this proposal will be distributed in the form of travel awards that will provide much needed assistance to the
ability young investigators and trainees to attend. The essential goals of the annual meeting include: 1) advancing
original research and related scientific endeavors in the field of leukocyte biology and host defense, 2) promoting
the career development of junior and new investigators interested in leukocyte biology, 3) disseminating
information about the field to the wider scientific and lay audience, and 4) encouraging the translation of basic
research in leukocyte biology to applications in the clinic. These goals will be achieved through three Aims:
Aim 1. To provide an innovative and scientifically progressive program, in a collegial forum, to address the
latest developments leukocyte biology. The agenda will include a total of 4 Plenary Sessions and 8 Concurrent
Sessions with a total of 19 invited speakers. Aim 2: To provide an opportunity for new investigators and trainees
to interact closely with established scientists. A significant innovation for the 2020 meeting will be the SLB-
SCHOOL (Society for Leukocyte Biology-Symposium for Career development and Hands-On Opportunity to
Learn) which will offer trainees a full day instructional workshop covering topics related to research regarding
the microbiome. The expectation is that enrollees will gain practical insight into this topic and more actively
participate with experts in the field. Aim 3: To promote diversity and inclusion in the field of leukocyte biology by
cultivating the participation of women, underrepresented groups and disadvantaged individuals. The Diversity,
Equity and Inclusion (DEI) committee will sponsor workshops and awards to encourage the participation of
women and scientists from underrepresented groups. In sum, the 2020 program is purposefully designed to
enhance awareness of the influence of leukocyte biology in health and disease and inspire young investigators.

Public health relevance
PROJECT NARRATIVE The proposed application is relevant to public health because the annual meeting of the Society for Leukocyte Biology will bring established scientists and trainees together who seek a better understanding of diseases that are caused by excessive, or poorly regulated, inflammation. The 55th meeting is committed to forging an international partnership between scientists in academia, industry and government who all seek to bring new medicines to clinical use for patients with immune disorders.